Strengths-Based Multi-Level Behavioral Intervention to Promote Resilience and Self-Management in Youth with Type 1 Diabetes

PROJECT ABSTRACT
Type 1 diabetes (T1D) management is challenging during early adolescence, a period often marked by
increasing expectations for independent self-management and poorer glycemic and quality of life outcomes. The
parent R01 is testing a multi-pronged intervention that uses strengths-based approaches to help youth achieve
“resilient” diabetes outcomes, including high engagement in T1D self-management behaviors, HbA1c levels
within the target range, and good quality of life. In this 6-month intervention: (1) parents use an app to recognize
and reinforce their children’s positive T1D-related behaviors, (2) youth use an app to have positive interactions
with parents and watch videos made by older adolescents with T1D about living well with T1D, (3) families have
weekly 5-minute meetings about a family diabetes goal related to self-management, and (4) diabetes care
providers lead a discussion with youth and parents about what youth are doing well for T1D during a routine care
appointment. Primary outcomes are HbA1c, % glucose time in range, engagement in T1D self-management
behaviors, and health-related quality of life. We are enrolling 250 racially/ethnically, socioeconomically, and
linguistically diverse youth in Houston, TX and Washington, DC, who are randomly assigned to the intervention
or enhanced usual care. Given known disparities among Latino people with T1D and historical exclusion of
Spanish speaking individuals in T1D research, the parent R01 includes active recruitment of people who solely
or primarily speak Spanish. However, recruitment and retention of Spanish speaking families requires additional
strategies and time, and guidance is needed to ensure our recruitment, engagement, and retention approaches
lead to adequate representation in this trial. Thus, this supplement aims to convene a community advisory board
(CAB) who will review and provide experience-based recommendations to improve the current procedures for
recruiting Spanish speaking families into the trial, engaging them in data collection and intervention activities,
and retaining them in the trial throughout the study period. CAB members will review participation rates of
Spanish speaking participants in the trial, provide suggestions to address challenges that arise, and partner with
the research team to collect and interpret data from Spanish speaking trial participants about their experiences
in the study. CAB activities will be conducted with guidance from the addition of a Co-Investigator with expertise
in Community Engagement Research in pediatric health populations. Through the supplement, we will dedicate
additional staff time and effort to focused enrollment and engagement with Spanish speaking families. The
ultimate goal of this research is to ensure high representation of Spanish speaking families of youth with T1D in
our behavioral research program testing a strengths-based intervention designed to promote optimal health
behaviors, psychosocial well-being, and T1D health outcomes during early adolescence. Results will inform
future interventions to maximize resilient outcomes for youth with T1D, including those from groups that have
been systematically excluded from research.

Public health relevance
PROJECT NARRATIVE Recognizing that clinical research in pediatric type 1 diabetes (T1D) has largely excluded Spanish speaking families and led to a lack of knowledge of effective methods to support medical and behavioral well-being in this population, our parent R01 is more inclusive than prior trials and includes Spanish speaking individuals as eligible participants in a randomized clinical trial of a strengths-based behavioral intervention for parents of early adolescents with T1D. With guidance from an additional Co-Investigator with expertise in in Community Engagement Research in pediatric health populations, this supplement proposal aims to convene a community advisory board (CAB) to partner with the research team to review and refine our team’s efforts to effectively recruit Spanish speaking families into the trial, engage them in data collection and intervention activities, and retain them in the trial throughout the study period. The supplement will also facilitate additional staff time and effort to targeted recruitment and ongoing communications with Spanish speaking families, and the study team will gather process data about the trial from Spanish speaking participants to inform future efforts to improve representation of Spanish speaking families in behavioral T1D intervention research.